Development of Models of Comprehensive Blood and Lymphatic Systems for Radiation Dosimetry

PROJECT SUMMARY
Radiation induced lymphopenia (RIL) occurs in approximately one-half of cancer patients receiving external
beam radiotherapy and this post-therapy condition has been shown to greatly reduce five-year survival rates. It
is theorized that RIL is induced by direct lymphocyte cell kill, suggesting that assessment of the radiation dose
to lymphocytes during radiotherapy is a necessary requirement for their consideration as a dose avoidance
structure. In order to facilitate the computation of radiation dose to circulating lymphocytes, their supporting
structures must be modeled in patient anatomic models used in tissue dosimetry. Currently, there exists no intra-
organ blood vasculature nor lymphatic vasculature nor specialized lymphoid tissue structures within the
International Commission on Radiological Protection’s (ICRP) reference computational phantoms – commonly
used as a digital model of medical patients. Additionally, there exists major inaccuracies in the inter-organ whole-
body blood vessels of these reference phantoms, and no modeling of microscale vasculature of blood or lymph
has been yet undertaken to account for their large portion blood and lymph within the human body. Additionally,
in applications of radiopharmaceutical therapy, blood self-dose, which is substantial for short-range radiations
such as alpha particles and lower-energy electrons, emitted by many common radiopharmaceuticals, cannot be
entirely quantified due to the lack of intra-organ vasculature in the ICRP phantoms. Dose to lymphatic vessels,
additionally can be computed for the first time in RPT applications with these models in place. Therefore, this
project hypothesizes that the development of a comprehensive model of blood and lymphatic vessels and
corresponding lymphoid tissues will facilitate the computation of blood and lymphocyte radiation dose for the first
time and will subsequently allow for consideration of circulating and non-circulating lymphocytes as organs-at-
risk in radiotherapy treatment planning. The proposed project will be achieved by the completion of four Specific
Aims: Aim 1: develop whole-body adult mesh models with intra-organ and inter-organ vasculature. Aim 2:
develop corresponding lymphatic tissue and vessel models. Aim 3: develop organ specific microscale blood and
lymph vasculature models. Aim 4: compute organ radionuclide S values for radiopharmaceutical therapy and
lymphocyte dosimetry for external beam radiotherapy. Completion of these aims will greatly improve the
computational models used as tools in reference medical dosimetry for a new assessment of dose to blood, as
well as set the stage for adaptation of these models via deformable registration to expand to patient-specific
modeling and personalized dosimetry.

Public health relevance
PROJECT NARRATIVE Radiation induced lymphopenia (RIL) occurs in approximately one-half of cancer patients receiving external beam radiotherapy and this condition is associated with a significant decline in five-year survival rates post- treatment. It is theorized that RIL is induced by direct lymphocyte cell kill, but reference computational models from the International Commission on Radiological Protection (ICRP) – used widely as anatomic patient models – do not currently include detailed blood and lymphatic systems necessary to consider lymphocytes as an organ at risk. This study proposes the development of a comprehensive blood and lymphatic system model residing within the ICRP reference phantoms for use in the computation of blood dose in radiopharmaceutical cancer therapy, and the computation of lymphocyte dose for radiotherapy treatment planning and optimization.